Automation of Liquid Nitrogen Freezer for Cryopreservation of Unique Human Biospecimens at the Vanderbilt Biospecimen Storage Facility

Project Summary
Large, high-dimensional clinical, genetic and biomarker data linked to bio-repositories are driving basic, clinical
and translational research. For the past 20 years, Vanderbilt University Medical Center (VUMC) has made
long-term strategic investments in translational sciences as a platform for excellence across clinical and basic
science departments and is internationally recognized as a leader in such fields as personalized medicine,
vaccinology, and cancer care and research. As examples, BioVU, Vanderbilt’s large-scale biorepository,
contains detailed de-identified human phenotype information linked to de-identified discarded samples and
genotypes. Viably cryopreserved human specimens enabled the Vanderbilt Vaccine Center to isolate
monoclonal antibodies against COVID-19 that were developed into Evusheld, a therapy to prevent COVID-19
in at-risk individuals. Cooperative Human Tissue Network at VUMC is one of only six funded by the National
Cancer Institute to procure and distribute human tissues to researchers throughout the US, Canada, and
internationally. These resources and others provide an accelerating engine of discovery. Collectively these
endeavors are providing powerful predictors of disease risk, disease progression or response to therapy and
underpinning studies delineating the fundamental mechanism of disease as well as translation to the clinic.
These large-scale initiatives generate a massive number of valuable human and animal tissue samples. These
tissues can only be viably cryopreserved when stored in liquid nitrogen. The size of these biorepositories is
exceeding the capacity of individual investigators or groups to effectively curate, maintain sample integrity and
rapidly retrieve samples for further study. Many of these materials could not be replaced and are of
international importance. To meet this large and growing need, a specialized automated -190°C Cryogenic
Freezer for Sample Storage system is necessary to manage, store and retrieve the tens of thousands of
biorepository samples. This proposal seeks to obtain funding for the purchase of an Azenta BioStore Cryo M60
robotic liquid nitrogen freezer system that can accommodate all large biorepositories at Vanderbilt. With such a
system Vanderbilt can provide the necessary institutional support, environment and expertise to ensure cost-
effective, quality assured management, storage and retrieval of these critical samples and reagents. The
technology is durable and scalable and therefore it can be predicted that this automated system will enable a
broad range of investigators and propel basic, clinical and translational research long into the future.

Public health relevance
Project Narrative Large repositories of biological samples represent critical resources for investigations of human disease. This proposal seeks to obtain funding for a state-of-the-art robotic -190°C Cryogenic Freezer that would allow consolidation of major biorepositories at Vanderbilt into a central system with improved safety for biobanks and more efficient management of sample data as well as entry and withdrawal of samples. This freezer will support multiple efforts at Vanderbilt to promote translational investigations into human diseases.